Novel diagnostic algorithms to improve antimicrobial management for Ugandan patients with chemotherapy-associated febrile illness

ABSTRACT: Over 1 million people with cancer live in African countries, 30-40% of whom are people with HIV
(PWH). Chemotherapy-associated febrile illness is a frequent complication that occurs during cancer treatment
and is associated with morbidity and mortality. Small-scale studies also suggest that the microbiology of
chemotherapy-associated febrile illness differs significantly for those living in Africa. For example, our previous
pilot study showed that 19% of Ugandans with solid tumors who developed chemotherapy-associated febrile
illness tested positive for tuberculosis (TB). Furthermore, PWH have higher rates of chemotherapy-associated
bone marrow suppression and are at increased risk for developing opportunistic infections when compared
with their HIV-negative counterparts. Yet, international guidelines for diagnosis and treatment of chemotherapy-
associated febrile illness do not reference any studies conducted in Africa and do not account for the patient’s
HIV status. Point-of-care (POC) tests are a potentially cost-effective way to identify the microbiologic causes of
febrile illness for patients living in low- and middle-income countries. Urinary lipoarabinomannan (LAM) is a
first-line POC test for TB diagnosis among PWH. However, the sensitivity and specificity of urinary LAM has
not been evaluated among patients with cancer. Given the high prevalence of HIV and TB throughout Africa, it
is critical to develop guidelines that incorporate HIV and TB diagnostics among patients with cancer. In this
study, we will use POC tests to develop a cost-effective diagnostic algorithm to guide antimicrobial
management for patients with solid tumors receiving chemotherapy in Uganda.
We proposed to use clinical microbiology diagnostics and next generation metagenomic sequencing to
understand the association between HIV status and the microbiology of chemotherapy-associated febrile
illness among Ugandan inpatients with solid tumors (Aim 1). We will assess the diagnostic accuracy of urinary
LAM to detect TB among febrile patients with cancer (Aim 2). Finally, we will create a diagnostic algorithm that
incorporates the patient’s HIV status and uses POC tests to guide antimicrobial management for patients with
chemotherapy-associated febrile illness among Ugandan patients with solid tumors to assess an optimal, cost-
effective diagnostic strategy (Aim 3).
The proposed research aims will support Dr. Gulleen in meeting her career development training goals
of 1) gaining proficiency in using metagenomic sequencing, 2) developing expertise in assessing the diagnostic
accuracy of POC tests among novel populations, and 3) learning principles of cost-effectiveness analysis. The
K23 award will facilitate her transition to an independent physician-scientist who evaluates and implements
novel diagnostic algorithms for managing chemotherapy-related infections among PWH. Dr. Gulleen will
conduct these activities with outstanding mentorship from experts in global health, metagenomic sequencing,
clinical laboratory diagnostics, and cost-effectiveness analysis.

Public health relevance
PROJECT NARRATIVE Chemotherapy-associated febrile illness is a major complication of cancer treatment and is associated with high morbidity and mortality, particularly for patients living in sub-Saharan Africa. The cause of fever in many cases is unknown, especially in places where the burden of HIV infection is high. For this project, we will evaluate the causes of fever among people with chemotherapy-associated febrile illness in an HIV and TB endemic setting.